Physical Activity, Vascular Function, and Brain Health in Multiple Sclerosis

Abstract
Multiple sclerosis (MS) is a chronic, immune-mediated inflammatory and neurodegenerative disease of the
central nervous system (CNS) that is associated with impairments in cognitive processing speed (CPS). The
impairments in CPS are poorly managed through medication or rehabilitation in MS, yet present considerable
burden for persons with MS. There is recent evidence of vascular dysfunction in MS, and this have been
associated with worse CPS in MS. Physical activity is associated with better vascular function and CPS in MS,
but the possible mechanism has been incompletely described and characterized. Cerebral pulsatility index
measured in the middle cerebral artery may reflect consequences of vascular dysfunction in large arterial and
cerebral microvascular segments, however in closer proximity to the brain than previously measured metrics of
vascular dysfunction in MS such as aortic stiffness. There are further data of elevated serum neurofilament
light (sNfL) levels in MS, and sNfL has been associated with cognitive and cerebrovascular endpoints in MS.
Collectively, this study compares and examines hypothesized associations among physical activity, measured
by body-worn accelerometry, brain vascular function, as measured by cerebral pulsatility index, cognitive
function, measured by CPS, and CNS neuronal integrity, measured with sNfL, in persons with MS compared
with controls matched for age, sex, and body mass index. The study will further examine cerebral pulsatility
index as a mediator of the associations among physical activity, sNfL, and cognition in MS. We hypothesize
that people with MS will have lower levels of physical activity, higher levels of sNfL, and lower CPS compared
with controls. Additionally, we hypothesize that higher physical activity will be associated with lower cerebral
pulsatility index, lower levels of sNfL, and higher CPS. We further hypothesize that the relationships between
physical activity and both sNfL and CPS will be indirect and accounted for by cerebral pulsatility index, and this
indirect, mediation association may be stronger in MS. This study will provide the groundwork for developing a
randomized controlled trial that changes PA behavior for preserving brain vascular function, neuronal integrity,
and cognition in people with MS.

Public health relevance
Project Narrative Persons with MS experience negative physiological and psychological consequences such as vascular dysfunction, declining neuronal integrity, and cognitive impairment that might be worsened by physical inactivity. The proposed study will provide a novel comparison of physical activity, cerebral pulsatility index, neuronal integrity, and cognitive processing speed between MS and controls, and further examine associations among these variables as well as providing understanding of putative cerebrovascular mechanisms mediating the relationship between physical activity and brain health measured with neuronal integrity and cognitive processing speed.